Discovery of genes required for expression or activity of fusion oncogenes

We began our work to discover genes required for expression or function of fusion oncogenes by using the results of a genome-wide RNAi screen designed to identify genes needed for the activity of the fusion oncoprotein EWS-FLI1. The development of this RNAi screen was a collaborative effort involving my laboratory and researchers from CCR's Pediatric Oncology Branch and the trans-NIH RNAi screening facility at the National Center for Advancing Translational Sciences (NCATS). EWS-FLI1 is an oncogenic transcription factor that occurs as a consequence of chromosomal rearrangements involving chromosomes 11 and 22. The majority of Ewing sarcomas (ES), cancers of the bone and soft tissue result from this chromosomal rearrangement. The genome-wide RNAi screen revealed the expression of the EWS-FLI1 fusion transcript is sensitive to the inhibition of the activity of specific splicing factors. We identified that expression of the EWS-FLI1 transcripts expressed in ES cells harboring translocations where the breakpoint in chromosome 22 occurs within a specific region of DNA requires the splicing factor HNRNPH1 to generate an in-frame mRNA. Depleting HNRNPH1 in ES cells where the breakpoint occurs within a specific region disrupts the expression and the activity of the EWS-FLI1 protein and reduces cell survival. Furthermore, we identified SF3B1, a major component of a protein complex required for splicing as a protein that ES cells are particularly dependent upon for cell survival. Ongoing studies are investigating the how HNRNPH1 facilitates the splicing of EWS-FLI1 in those ES cells that dependent upon its function with the long-term aim of identifying means in inhibiting this process. We are also investigating the function other proteins identified as required for the expression of the EWS-FLI1 protein, including one that regulates oncoprotein stability.